Elacridar: Identification of the Molecular Target Relevant to its Anti-Prion Effects and its Application to Other Protein Misfolding Neurodegenerative Diseases

Prion diseases, while exceptionally rare, have provided a road map to link many protein misfolding
neurodegenerative diseases in profound mechanistic ways including the prion-like spread of pathological protein
aggregates from cell-to-cell and the neurotoxicity induced by soluble oligomers of these assemblies. Prion
diseases also affect other animals, including model organisms (and immortalized cell lines), making them the
only neurodegenerative disease that can be directly studied in laboratory experiments. This unprecedented
scenario has allowed for the testing and characterization of small molecule therapeutics under real life conditions.
We have recently discovered a novel anti-prion compound, elacridar, and preliminary data suggests that it exerts
its effects through activating the lysosome, the organelle responsible for the degradation of unwanted proteins.
Because of the central role of lysosomes to protein degradation, we extended these studies to determine that
elacridar is also efficacious against misfolded α-synuclein and tau, proteins associated with more common
neurodegenerative diseases.
In this application, we propose experiments designed to define the mechanism of action whereby elacridar exerts
its anti-prion effects through identification of the intracellular site(s) where it accumulates, the accompanying
proteomic changes induced by this accumulation, and the identification of the molecular target responsible for
these effects. We also propose to further explore the effects of elacridar against pathologically misfolded forms
of α-synuclein and tau using assays to monitor their cell-to-cell spread, degradation, and neurotoxicity. We
anticipate that the knowledge gained by these investigations will provide novel therapeutic targets for the
treatment of neurodegenerative diseases.

Public health relevance
Prion diseases are fatal neurodegenerative disorders with biological principles that apply to other neurodegenerative diseases including Alzheimer’s disease, Parkinson’s disease, and frontotemporal dementia. This proposal aims to define the mechanism of action of a novel anti-prion compound that also has activity against pathological aggregates found in some of these more common diseases. This knowledge will provide new therapeutic targets for the broad treatment of these devastating conditions.